Monoclonal antibody isolation and characterization for COVID-19 Effort

To date, we have isolated more than 100 SARS-CoV-2-specific monoclonal antibodies (mAbs) from SARS-CoV-2 convalescent donors and characterized their functionality in vitro. More than 25 of the mAbs isolated and characterized were neutralizing against SARS-CoV-2 with several showing pan-coronavirus neutralization (i.e. the ability to neutralize SARS-CoV-2, multiple Variants of Concern (VOC) as well as SARS1 and other SARS1- and SARS2-related coronaviruses).

Structures of 5 pan-coronavirus neutralizing mAbs were solved, revealing that 2 of the mAbs disrupt/dissociate the spike trimer and target a relatively conserved epitope. Results describing the isolation, characterization, and high resolution structures of our pan-coronavirus neutralizing mAbs in complex with SARS-CoV-2 spike, are being prepared for publication.